Metabolic interactions in the vascular wall: an integrated experimental and computational approach

Project Summary
Nearly 1 in 3 American adults has metabolic syndrome, a complex disorder defined by elevations in blood
sugar, cholesterol, and triglycerides. Patients with metabolic syndrome have a high cardiovascular disease risk
due to interactions among the elevated blood metabolites. However, since we do not have good methods for
studying integrated and interacting metabolic changes, we treat each metabolic abnormality individually. As a
result, patients are often on multiple medications, potentially decreasing the ability of each drug to normalize
blood metabolites and raising the risk for negative drug interactions.
In this project, we propose a novel integrated experimental and computational bioengineering approach to
study how metabolic abnormalities contribute to cardiovascular disease. Specifically, we will study metabolic
interactions between endothelial cells, which line the inside of the blood vessels, and vascular smooth muscle
cells, which contribute to cardiovascular disease when they change their function. We will engineer a
computational isotope-assisted metabolic flux analysis (iMFA) model, which uses experimental mass
spectrometry data to estimate intracellular metabolic fluxes and metabolite transport. The computational model
will enable us to develop new hypotheses for and plan studies into how metabolic changes (from altered blood
metabolites or therapies) affect the vascular wall.
We hypothesize that EC metabolic dysfunction increases the transport of metabolites that promote VSMC to
switch from a contractile to a synthetic phenotype. In turn, synthetic vSMC enhance EC metabolite transport to
support proliferation. To explore this hypothesis, we will combine in vitro, in silico, and ex vivo studies to: 1)
Determine how EC dysfunction in altered metabolic environments impacts metabolite transport; 2) Measure how
altered metabolites synergistically shift vSMC to a synthetic phenotype; and 3) Investigate how EC-vSMC
crosstalk impacts cell metabolism and phenotype in the vascular wall.
We will start with single cell models of endothelial and vascular smooth muscle cells, which will simulate the
diversity of human nutrient levels. We will the integrate the two cell types to understand their crosstalk in vitro,
in silico, and ex vivo. At each step, we will relate metabolism to cell phenotype and function to link the model to
cardiovascular disease.
The computational iMFA model of integrated endothelial-vascular smooth muscle cell metabolism, transport,
and function will enable us to develop new hypotheses for and plan studies into how metabolic changes from
altered blood metabolites or therapies affect the vascular wall. By changing the parenchymal cell type, the model
can then be extended to study vascular metabolic interactions in other tissues (e.g., brain) and shed light into
other diseases in which integrated EC metabolism and transport (e.g., Alzheimer’s disease).

Public health relevance
Project Narrative High blood sugar, cholesterol, and fat increase a person’s risk of developing heart disease. We treat each of these changes individually, which means that our treatments are not as effective as they could be. In this project, we will create a computer program to help us understand how altered blood sugar and fat interact to change the function of our blood vessels and lead to heart disease.